2025 Mechanisms of Membrane Transport Gordon Research Conference and Seminar

Project Summary
The 2025 Gordon Research Conference (GRC) on Mechanisms of Membrane Transport will be held at the
Les Diablerets Conference Center, Switzerland, from May 25 to May 30, 2025. This marks the 29th conference
in the highly esteemed GRC series, which has been ongoing since 1966. The theme of the 2025 GRC is
“Crossing the Boundaries: Unraveling Molecules, Medicine, and Membrane Transport Mechanisms", focusing
on the discovery of new membrane transport proteins, innovative methodologies for studying membrane
transport, and the identification of new pharmacological interventions for various diseases. Concurrently, the
2025 Gordon Research Seminar (GRS) on Mechanisms of Membrane Transport, organized by graduate
students and postdocs, will be held from May 24 to May 25 at the same venue. The theme of the 2025 GRS is
“Understanding the Biological Role of Transporters and Channels”, concentrating on research within the context
of how transport mechanisms contribute to health and disease, complementing the associated GRC's focus on
the therapeutic opportunities these proteins present. The overarching goal of the 2025 GRC/GRS is to bring
together scientists from all levels – from students and postdoctoral fellows to early-career researchers and
leaders in the field – to advance our fundamental understanding of membrane transport function in cell
membranes, promote diversity within the field, foster networking and collaborations, provide opportunities to
share research and learn from others, and receive valuable mentorship from invited senior scientists. To
accomplish these objectives, we have already invited and received commitments to participate from eminent
scientists across many institutions, nations, and scientific fields. The conference plan includes ample discussion
time, both formally after talks and informally during shared meals and organized activities, for attendees to
exchange ideas and establish collaborations. More than half of our selected speakers are women, and 12% are
from underrepresented minority groups. We are committed to recruiting a similarly diverse group of attendees
through our meeting announcements. To support rising leaders in the field, the associated GRS will feature a
panel of senior scientists who will share their experience navigating various complex career transitions commonly
encountered by trainees as they mature as scientists. With these objectives and plans, we are confident that this
conference will build upon the well-established success of the Mechanisms of Membrane Transport GRC.

Public health relevance
Project Narrative The 2025 Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) on Mechanisms of Membrane Transport will be held at the Les Diablerets Conference Center, Switzerland, from May 24 to May 30, 2025. The overarching goal of the 2025 GRC/GRS is to bring together scientists from all levels – from students and postdoctoral fellows to early-career researchers and leaders in the field – to advance our fundamental understanding of membrane transport function in cell membranes, promote diversity within the field, foster networking and collaborations, provide opportunities to share research and learn from others, and receive valuable mentorship from invited senior scientists.